Training Program in the Neuroscience of Human Cognition

This proposal describes the continuation of the Training Program in the Neuroscience of
Human Cognition. A group of 23 faculty preceptors—investigating perception, attention,
memory, emotion, problem solving, language, pain, sleep, motor control, and cognitive
control—has been assembled to participate in training the next generation of cognitive
neuroscientists at Northwestern University. The training program is led by Christina Zelano
and Rodrigo Braga, (Directors), Ken Paller (Associate Director), and an Internal Steering
Committee, with annual input from members of an External Advisory Committee. Pre- and
postdoctoral trainees are selected through a highly competitive process on the basis of
factors including prior scientific training, proposed research, scientific potential. Funding
from the Northwestern Graduate School supports Affiliate Trainees who also participate in
the program. Trainees conduct their research under the guidance of one or more
preceptors affiliated with many different departments and centers within the university. To
provide thorough training in all facets of cognitive neuroscience, the training program brings
together a broad set of perspectives to facilitate a wide range of methodological,
computational, and theoretical endeavors. Exceptional opportunities are provided for
trainees to learn from and closely interact with local and visiting faculty members, and with
other trainees, in the service of expanding their capacity for rigorous and creative research
on the neural substrates of cognition and associated translational opportunities. Trainees
gain from frequent in-depth research discussions with a network of scientists outside their
home lab, including regular presentations and critique of their own work. Trainees often
bridge the distinct areas of expertise of two mentors through novel interdisciplinary
collaborations, expanding their breadth of training. This T32 mechanism solidifies a
community for all involved in human cognitive neuroscience at the university, while
facilitating novel research orientations and innovative strategies. Value-added benefits for
trainees include a rich array of activities that supplement standard research training,
allowing them to expand their training beyond lab and departmental boundaries in ways
that would otherwise not be possible. The community fosters training in specific research
skills, while also supplying relevant knowledge to help trainees gain independence and
become better scientists. Faculty monitor this training through formal advising, written and
oral scientific communication, regular evaluations, and with attention to all aspects of
career development. A chief goal of the program is to provide top-rated comprehensive
training to young scientists who will become future innovators and leaders in human
cognitive neuroscience, contribute to NIH research, and ultimately bring their skills to bear
on a variety of scientific endeavors pertinent to health and disease.

Public health relevance
Project Narrative Cognition is the focus of human achievement and is essential for human success, but it is also the focal point of the most malicious attacks on health, giving rise to immense suffering and a high emotional and monetary cost in our society. Treating and preventing neurological and psychiatric disease, as well as the cognitive decline of aging, depends on understanding the cognitive problems presented in the clinic, which in turn depends on understanding the brain bases of these problems. The Training Program in the Neuroscience of Human Cognition is primed to contribute to these endeavors by delivering a steady infusion of young scientists with the high-quality training and the necessary experiences and guidance to prepare them to become scientific leaders and valuable contributors to this agenda.